Bayesian analysis of structural shape and conformation

DESCRIPTION (provided by applicant): Accurate analysis of structural differences and commonalities is of fundamental importance for understanding the structure, function, and evolution of biological macromolecules. For the past 40 years, structural analysis methods have relied on the biophysically unrealistic and restrictive least-squares criterion to find optimal superpositions. By developing probabilistic models of structural change that can take advantage of powerful maximum likelihood (ML) and Bayesian techniques, this proposed work will greatly expand our abilities to accurately superposition, align, and analyze structural conformations. The specific aims of this work are (1) to develop Bayesian models and theory for superpositioning structural conformation, (2) develop ML and Bayesian models and theory for multiple structure-based alignment, and (3) develop and distribute computational tools that implement this ML and Bayesian structural analysis. ML and Bayesian structural analysis will provide many distinct advantages over current least-squares and other ad hoc methods, including (1) straight- forward estimates of the uncertainty in the solutions of estimated parameters, (2) elegant handling of uncertainty in structural data, (3) natural incorporation of disparate types of prior structural and molecular information, (4) easy examination of complex models of structural change and evolution, (5) rigorous testing of complex structural hypotheses, and (6) natural handling of missing structural data. While we concentrate specifically on the conformations of macromolecules, the methods proposed herein have broad mathematical generality and will impact not only molecular structural biology but also an unusually wide range of scientific fields, including any that compare the shapes and conformations of objects. The results developed from this work will be applicable to any entity that can be represented as a set of Cartesian points in a multi-dimensional space, whether the particular structures under study are proteins, skulls, MRI scans, geological strata, or even psychological profiles of human individuals.

Public health relevance
PUBLIC HEALTH RELEVANCE: Measuring, analyzing, and comparing the shapes and conformations of the structures of objects is of fundamental importance in many diverse scientific fields. Our particular focus is the development of likelihood and Bayesian methods for the comparison and analysis of multiple three-dimensional macromolecules. While we concentrate specifically on the conformations of macromolecules, the methods proposed herein will be generally applicable to any entity that can be represented as a set of Cartesian points in a multi-dimensional space, whether the particular structures under study are proteins, skulls, MRI scans, geological strata, or even psychological profiles of human individuals. PROJECT NARRATIVE Measuring, analyzing, and comparing the shapes and conformations of the structures of objects is of fundamental importance in many diverse scientific fields. Our particular focus is the development of likelihood and Bayesian methods for the comparison and analysis of multiple three-dimensional macromolecules. While we concentrate specifically on the conformations of macromolecules, the methods proposed herein will be generally applicable to any entity that can be represented as a set of Cartesian points in a multi-dimensional space, whether the particular structures under study are proteins, skulls, MRI scans, geological strata, or even psychological profiles of human individuals. __SpecificAimsTextDelimiter__ Specific Aims Accurate analysis of structural differences and commonalities is of fundamental importance for understanding the structure, function, and evolution of biological macromolecules. For the past 40 years, structural analysis methods have relied on the biophysically unrealistic and restrictive least-squares criterion to find optimal superpositions. By developing probabilistic models of structural change that can take advantage of powerful maximum likelihood (ML) and Bayesian techniques, this proposed work will greatly expand our abilities to accurately superposition, align, and analyze structural conformations. ML and Bayesian structural analysis will provide many distinct advantages over current least-squares and other ad hoc methods, including (1) straightforward estimates of the uncertainty in the solutions of estimated parameters, (2) elegant handling of uncertainty in structural data, (3) natural incorporation of disparate types of prior structural and molecular information, (4) easy examination of complex models of structural change and evolution, (5) rigorous testing of complex structural hypotheses, and (6) natural handling of missing structural data. Because of their mathematical generality, the results developed from this work will impact not only molecular structural biology but also an unusually wide range of scientific fields, including any that compare the shapes and conformations of objects. 1: Develop Bayesian models and theory for superpositioning structural conformation Probabilistic models of differences in structural conformation are necessary for ML and Bayesian model-based methods. By incorporating physically and biologically realistic assumptions, these models will allow for more accurate and more general structural analyses than conventional least-squares methods. (A) Formulate and solve a Bayesian treatment of the superposition problem, using a Gaussian model and non-isotropic covariance matrix (which allows each atom to have a different variance and to be spatially correlated with other atoms). Find conditional densities for use in a Gibbs sampling algorithm. Determine solutions using both reference priors and explicit, proper priors. Develop Metropolis-Hastings methods where Gibbs sampling is impossible. Determine conditions sufficient for the propriety of the posterior. (B) Incorporate scale factors in ML and Bayesian models. Scale factors allow objects of different sizes to be analyzed. For instance, abstract representations of protein folds using secondary structure elements should be independent of size, since only topology and connectivity are of interest. (C) Allow for missing data in both ML and Bayesian analyses of structural conformation. When comparing, say, multiple homologous proteins, current methods simply ignore (exclude) regions that are not fully shared among all proteins. ML and Bayesian methods can allow for the inclusion of all relevant structural data. 2: Develop ML and Bayesian models and theory for multiple structure-based alignment The structural alignment problem, in which homologous, corresponding residues are unknown a priori, is a different and more difficult bioinformatic problem than the superposition problem. Previous Bayesian work has provided techniques for pairwise structure-based alignments. We will extend and improve these results by allowing for fast, high-throughput, simultaneous alignment of multiple structures. (A) Develop ML and Bayesian methods for ultra-fast, simultaneous structure-based alignment of proteins. (B) Incorporate prior information from amino acid sequence data and secondary structure data. (C) Incorporate probabilistic models of structural evolution and dynamic conformational change/motion. 3: Develop and distribute computational tools for ML and Bayesian structural analysis (A) Create a public website for performing ML and Bayesian structural superpositions and alignments. (B) Create and maintain a curated database of ML and Bayesian superpositions of NMR models. (C) Rewrite, clean, optimize, distribute, and maintain our ML superposition software THESEUS. (D) Develop, code, distribute, and maintain Bayes-THESEUS, a new program for performing Bayesian superpositions, providing both maximum aposteriori (MAP) and full posterior distribution solutions (using a Gibbs/Metropolis-Hastings MCMC algorithm). (E) Develop, distribute, and maintain source code libraries for performing ML and Bayesian structural analyses. These libraries will be constructed using multiple programming languages, including standard C, python, and R scripts. These libraries will be made freely available to the research community for incorporation into previously existing and novel software.